ADMINISTRATION UNIT

This section explains the structure and function ef our center Administration Unit, which includes the Center Adviser Committee (CAC), PS-OC Steering Committee (PSC), and ether internal advisory committees that will be formed te ensure effective communications, management, scientific productivity, oversight and evaluation.